Beyond Barriers: Leveraging Community Expertise for Improved Neurological Health among U.S. Resettled Refugees

PROJECT SUMMARY
Refugees represent a highly marginalized population with staggering health disparities, driven largely by their social
determinants of health across the displacement continuum. Peer-delivered interventions offer a promising scalable
mechanism for addressing these disparities, whose relevance, effectiveness, and sustainability can be enhanced when
developed with rigorous community engagement principles and practices. This proposal aims to leverage a strengths-
based, community-engaged approach to 1) capture experiences of refugees with neurological illness; 2) adapt and test the
feasibility and acceptability of a peer support intervention to inform a future robust trial; and 3) build long-term capacity
for community-partnered clinical research addressing neurological disparities among refugees.

Public health relevance
PROJECT NARRATIVE Refugees have staggering health disparities compared to the general population, including higher prevalence of, and disparities of care across neurological conditions. Their health vulnerability is driven largely by social determinants of health, such as access to water, nutritious food, residential location, socioeconomic status, exposure to violence, stigma, and marginalization. These social factors influence health outcomes across the displacement continuum, from pre-migration experiences in their home country, to the migration journey across land or water, to post-migration resettlement. There is a critical need for effective interventions that address this significant burden. This can include peer support interventions that have been shown to be effective in chronic disease management, including with hard-to-reach and marginalized populations. Yet these interventions are under-utilized within neurology and rarely developed in partnership with communities. This is despite the potential to enhance interventions’ relevance, effectiveness, and sustainability when developed with rigorous community engagement principles and practices. Community engagement uplifts community voice in an equal partnership between researchers and the community being studied, thereby enhancing potential to improve health outcomes. Our proposal seeks to use Photovoice and Community Engagement (CE) Studios—two established methods for community engagement to (1) capture experiences of refugees with neurological illness, including how social determinants of health contribute to these experiences, and identify multi-level factors that facilitate or hinder seeking neurological care (Photovoice, Aim 1); (2) adapt a peer support intervention, including refining and standardize a protocol with our community partners (CE Studios, Aim 2, to be integrated with results from Aim 1), (3) test the feasibility and acceptability of the intervention, including further intervention refinement to inform a future robust trial (Aim 3), and (4) build capacity for future community-engaged and partnered clinical studies or trials focused on neurological disparities among refugees (all Aims). This planning grant will focus on three neurological conditions we have identified as most salient in our preliminary work: a) headache disorders, b) traumatic brain injury, and c) sleep disorders. However, the hope is for the intervention to be transdiagnostic, with core modules that span diagnoses (i.e., active listening and goal setting) and one module for each specific neurological condition. The long-term goal is to decrease neurological health disparities among refugees. We will focus on English and Spanish-speaking refugees, who are predominantly from African, Middle Eastern and Latin American countries. This population aligns with NIH-designated populations that experience health disparities both due to racial/ethnic category and socioeconomic status, as many refugees are socioeconomically disadvantaged. This project is led by a multi-institutional, multi-disciplinary, and diverse research team with over 20 years of expertise working with refugees and community partners for local and national projects. Practitioner and community partners include the Society of Refugee Health Providers and the Resettled Refugee Review Board, a national community advisory board of resettled refugees. This work will fill a critical gap in developing scalable, community-engaged interventions to mitigate neurological health disparities and transform the landscape of refugee care provision to improve their health and well-being.